Linking Genetic and Clinical Data to Optimize Surgical Opioid Analgesic Prescribing and Predict Risks of Opioid-Related Adverse Drug Events

PROJECT SUMMARY
While opioid drugs are very effective for controlling pain, they are highly addictive. The current clinical decision
making for post-surgical opioid prescribing is still based on oversimplified information. Both opioid use disorder
and opioid-related pain response have strong genetic underpinnings. A better system is needed to guide the
clinical use of genotype data and facilitate better-informed opioid prescribing decision-making.
Electronic health record (EHR) offer a largely untapped source of information to conduct clinically oriented
studies. By integrating genomic data and EHR dataset in large-scale clinical Biobank, we can now perform
"clinical-driven genomic research". This approach is particularly robust for complex diseases with a genetic
susceptibility.
I propose to develop a model to recommend optimal opioid dosage (oral morphine milligram equivalents) for
post-surgical pain relief and predict the risk of post-discharge harmful outcomes. The large-scale clinical and
genomic databases from the Mass General Brigham (MGB) healthcare system, including eight hospitals that
share a centralized database, will be utilized for model development. The proposed research will not only have
strong immediate potential to improve clinical practice in this urgent area but will also provide strong
preliminary work to support my first NIH R01 application.
From the previous projects, I have developed opioid use disorder clinical phenotypes and identified associated
genetic markers. I have also developed machine learning models to predict risks of complex diseases and
explored clinical application potentials. The proposed project will combine my existing analytical skills with the
newer expertise that I seek to develop through this award program, including a nuanced understanding of
analgesic strategies, addiction, and implementation of clinical decision support systems, as well as artificial
intelligence applications in healthcare system.
I have invited several established investigators to form a strong, multi-disciplinary mentorship team. They
include experts in the fields of addiction, pain management, genetic analysis, implementation methods and
artificial intelligence techniques. With their support, I intend to dedicate my longer-term research career to
study functional genomics in the fields of opioid addiction and pain by using integrated analysis of harmonized
big data. The K01 program outlined in this application will provide timely and strategic support for my continued
advancement towards those goals.

Public health relevance
PROJECT NARRATIVE This proposal aims to quantitatively evaluate effects of opioid drugs on post-surgical pain relief and risk of opioid-related adverse drug events using patient-level clinical and genetic information. Statistical and machine learning models will be developed to recommend optimal opioid prescription dosage (oral morphine milligram equivalents). Polygenic risk score will be built to represent patients' genetic susceptibility to the given post- surgical opioid prescription-related outcomes and identify high-risk patient populations.